Novel Mechanisms of Pulmonary Fibrosis

This proposal explores the role of a pulmonary osteoclast-like cell (POLC) in silicosis. We first discovered POLCs
while studying pulmonary alveolar microlithiasis (PAM), a rare, autosomal recessive disorder caused by
mutations in the epithelial sodium phosphate co-transporter, Npt2b. Phosphate accumulates in the alveolar lining
fluid and complexes with calcium to form spherical hydroxyapatite microliths containing bone matrix proteins and
surfactant components. Contact of microliths with tissue resident alveolar macrophages (TR-AM) and recruited
monocytes (Mo-AM) induces osteoclastic transformation in the Npt2b-/- mouse, with expression of the full
repertoire of osteoclast signature gene and protein expression in multinucleated giant cells (MNGC) including
tartrate resistant acid phosphatase (TRAP), cathepsin K (CTSK), calcitonin receptor (CALCR) and the proton
pump, ATP6V0D2. Single cell RNA sequencing (scRNAseq) of human PAM lung also confirmed a robust
osteoclast signature in AM, and IHC confirmed the presence of TRAP and CTSK positive MNGC. Like humans,
Npt2b-/- animals develop modest pulmonary fibrosis and a marked restrictive physiologic defect. We found that
microliths induce alveolar expression of the requisite osteoclastogenic cytokines for POLC differentiation (i.e. M-
CSF, RANKL) and expression of hydrochloric acid and CTSK that both dissolve stones and damage tissues. We
were surprised to find that the Npt2b-/- mice also develop pulmonary alveolar proteinosis, which has not been
reported in PAM, but is known to be associated with another particulate exposure syndrome, silicoproteinosis.
This led us to consider that osteoclastic transformation of TR-AM and Mo-AM is a stereotypic response to inhaled
particles, resulting in the concomitant loss of AM surfactant catabolic and host defense functions (in the form of
susceptibility to Tb). Indeed, snRNAseq, rtPCR measures of gene expression and IHC assessments revealed
that silica challenge is also associated with RANKL-dependent osteoclastic transformation of BAL and
parenchymal cells, and TRAP, CTSK and hydrochloric acid production, culminating in destructive remodeling
and pulmonary fibrosis, and associated with a decrease in proteins required for lipid metabolism. Anti- RANKL
treatment of mice attenuates the silicoproteinosis, POLC formation, fibrosis and the restrictive physiologic defect
that occurs in silica-challenged mice. The differential tissue responses to dissolvable vs. persistent particulates
forms the basis for our hypothesis that persistent acid and matrix degrading enzymes produced by POLC may
be primary drivers of particulate-induced fibrosis. To test this hypothesis in three aims, we will determine; 1) Cell
lineages and alveolar factors that give rise to POLC; 2) The role of osteoclastic functions and products in silica-
induced fibrosis; and 3) The role of POLC in the pathogenesis of pulmonary fibrosis, in vivo. This proposal directly
addresses mechanisms relevant to the alarming rise in the prevalence of progressive massive fibrosis in black
lung claimants, and successful completion of the aims will provide preclinical evidence supporting anti-
osteoclastic strategies such as bisphosphonates and anti-RANKL in exposed subjects.

Public health relevance
Project narrative Scarring in the lung can occur after inhalation of silica, asbestos and other particles, but no one knows how or why that happens. We believe that non-degradable particles reprogram cells in the lung to produce acid and other factors in a futile attempt to dissolve them, which causes collateral injury and fibrosis in surrounding tissues. The tissue damaging cells have many similarities to osteoclasts, cells that dissolve bone, which are eminently targetable with bisphosphonates and other readily available and FDA approved agents if our theory proves to be correct.